UG1 - NCTN (Network Lead)

PROJECT SUMMARY
This application supports the participation of the University of the Chicago Medicine Comprehensive Cancer
Center (UCCCC) as a Lead Academic Participating Site (LAPS) in the National Clinical Trials Network (NCTN).
The NCTN develops and performs state-of-the-art early and late stage clinical trials for the treatment of adults
with cancer. UCCCC has been a long-standing member of the Alliance for Clinical Trials in Oncology and NRG
Oncology, and of the cooperative groups that preceded the formation of the NCTN. The UCCCC will provide
multi-disciplinary scientific and administrative leadership in the design of innovative and potentially practice-
changing clinical trials within the NCTN. UCCCC faculty members will contribute to the NCTN as operational
leaders, committee chairs, committee vice-chairs, committee leaders, and study chairs, and as members of
NCI Advisory and Scientific Committees. Preliminary studies performed by UCCCC investigators at the
University of Chicago will be brought to the NCTN for large scale testing. Laboratories at the University of
Chicago will perform correlative studies that will support NCTN trials. University of Chicago senior faculty will
mentor young investigators to become future leaders in the NCTN. The UCCCC has the infrastructure for the
initiation and conduct of a wide spectrum of clinical trials, supported through the Cancer Clinical Trials Office
(CCTO), the primary component of the Clinical Protocol and Data Management (CPDM) unit of the Cancer
Center Support Grant, which manages the regulatory activities for all adult cancer-related clinical trials. NCTN
LAPS activities at UCCCC will be coordinated by a Steering Committee, comprised of 4 Principal Investigators
who represent medical, surgical, radiation, and gynecologic oncology, and 2 senior administrative leaders in
the UCCCC. The Steering Committee will oversee the NCTN Coordinating Center in the Cancer Clinical Trials
Office, which will provide centralized regulatory oversight and data quality control support for the
implementation, quality execution of, and efficient accrual to, NCTN trials across the Network. UCCCC will
collaborate with the Network Group Operations Centers and the associated Network Group Statistics and Data
Management Centers to achieve the research goals of the NCTN program. The UCCCC will thus provide a
mechanism for robust accrual to trials across the NCTN, with participation across all tumor types, including
trials for rare cancers and in a diverse patient population, at the UCCCC main campus in Hyde Park, at 3
Integral Network sites, and at 3 LAPS-aligned affiliate institutions.

Public health relevance
PROJECT NARRATIVE NCTN trials set the standards for cancer treatment in the United States and across the world. The significant recent advances in the basic sciences cannot benefit patients unless new treatments are proven safe and beneficial in the clinical setting. UCCCC will contribute to the goals of the NCTN by providing the scientific leadership to develop trials that have a significant impact on treatment and the infrastructure to effectively accrue to clinical trials across the NCTN.